Clinical Centers for Completion of Ongoing MFMU Network Protocols

Abstract
The University of Pennsylvania’s Department of Obstetrics and Gynecology reflects a long tradition of
excellence in clinical and translational research. In this application, we provide information on our obstetrical
service and our proven track record for conducting clinical trials for the Maternal-Fetal Medicine Units (MFMU)
Network at the two hospitals in the University of Pennsylvania Health System (Penn) – the Hospital of the
University of Pennsylvania (HUP) and Pennsylvania Hospital (PAH). Each year, approximately 9,500 women
are delivered at Penn, and many of these women are high-risk pregnancies. The obstetric population at Penn
also has a diverse racial and ethnic background, which is an important asset for enrollment in MFMU Network
studies. Over the past five years, MFMU Network investigators and research staff at Penn have developed the
clinical research infrastructure and proven track record to meet all of the objectives of the ongoing MFMU
Network studies. Key assets of the MFMU Network clinical center at Penn are: 1) an experienced Nurse
Coordinator who oversees all of the clinical studies; 2) a second registered nurse who will be critical for
completion of the network’s PACT study; 3) a project manager who assists the Nurse Coordinator with
management of the study protocols; 4) an experienced clinical research coordinator who is certified to conduct
all MFMU Network studies; 5) a biospecimens technician who oversees collection, processing, and storage of
biospecimens; 6) a 24/7 model that provides research staff coverage every day on the labor floors at HUP and
PAH with call coverage at night; 7) outpatient recruitment at all major clinical sites at HUP and PAH; and 8)
data abstraction manuals written by research staff and investigators that ensure accurate ascertainment of
clinical data from the electronic medical record. The MFMU Network research staff work closely with
coordinators from the Neonatal Research Network at the Children’s Hospital of Philadelphia to provide
neonatal follow-up for MFMU Network studies. The investigative team for the MFMU Network clinical center at
Penn has significant experience directing multicenter studies, and each investigator has an exciting research
agenda that adds unique perspectives to the MFMU Network. The PI (S Parry) serves on the TXA protocol and
biospecimen committees, while the alternate PI (S Srinivas) serves on the PACT protocol committee and meta-
analysis work group. The investigators propose three specific aims for this application: 1) To work
within the collaborative environment of the MFMU Network toward the implementation of the ongoing
MFMU Network studies; 2) To provide the highest quality data for MFMU Network studies and to
provide these data in a timely fashion; and 3) To be involved in the analysis and publication of studies
performed by the MFMU Network. The investigative team at Penn looks forward to continuing to work with
the other clinical centers and the Data Coordinating Center to complete the ongoing MFMU Network protocols.

Public health relevance
Project Narrative The Maternal Fetal Medicine Units (MFMU) Network performs clinical trials that provides for improved care and treatment of women and their fetuses; thus, allowing for improved outcomes in maternal and child health. The clinical research environment in the Department of Obstetrics and Gynecology at Penn is exciting and continually growing, and the outstanding leadership team of the MFMU Network clinical center at Penn reflects a strong commitment for ongoing engagement by the department in the MFMU Network. The investigative team at Penn has built a highly successful MFMU Network clinical site, and we look forward to continuing to work with the other clinical centers and the Data Coordinating Center to complete the ongoing MFMU Network protocols.